Worklife Center for Excellence Iowa Stakeholder Conference

[unreadable] DESCRIPTION (provided by applicant): The University of Iowa Healthier Workforce Center of Excellence seeks to hold a stakeholder conference to make Iowa stakeholders aware of the NIOSH Worklife Initiative, the Worklife Center Program which includes the Iowa Center and to disseminate the results of the conference in Iowa and nationally via Elluminative Live, an innovative internet based sofware used extensively by the HWCE to disseminate its seminars, research and other educational programs. [unreadable] [unreadable] [unreadable]